Exploring Hepatitis B Virus PreCore Gene Functions in Woodchucks

Abstract
Chronic HBV infection is a critical public health problem affecting approximately 296 million individuals
worldwide. A better understanding of the underlying mechanisms of HBV persistence will facilitate the
development of new antivirals for the treatment of chronic HBV infection; however, these efforts are hampered
by deficiencies in current animal models susceptible to HBV infection. The Eastern woodchuck, naturally infected
with the woodchuck hepatitis virus (WHV) that is closely related to HBV, is a well-established animal model for
the study of HBV infection. The HBV PreCore gene, which encodes the secreted e antigen (eAg), is the least
characterized viral gene due to technical constraints. Studies in woodchucks have shown that the PreCore gene
is dispensable for WHV replication but necessary for facilitating chronic infection. We have recently discovered
a novel PreCore-encoded protein, named PreC, which is also secreted in HBV-infected patients and
chimpanzees and in WHV-infected woodchucks following alternative processing to eAg. Both the HBV and WHV
PreC and eAg show heterogeneous density distributions. These results suggest that the PreC protein may have
a function(s) distinct from eAg to facilitate chronic infection, and that both PreC and eAg functions may be related
to their density distributions. Thus, in Aim 1 we propose to explore the functions of PreCore-derived proteins in
modulating WHV infection. This will be achieved by liver transfection of woodchucks with a WHV construct
containing a single point mutation, which increases the efficiency of signal peptide cleavage and thus increases
the eAg level relative to PreC, and by comparing the course of infection by the mutant to wildtype WHV. In Aim
2, we propose to explore the dynamic changes of the WHV PreC/eAg density profile during infection and antiviral
treatment in woodchucks and the composition of the HBV and WHV low-density PreC/eAg populations. This will
be achieved by analyzing a large set of archival serum samples from woodchucks infected as neonates or adults
or treated with nucleos(t)ide analogs or interferon-alpha. Presence of the low-density PreC/eAg population may
cause or at least be associated with the chronic outcome of WHV infection, while reduction or loss may be
associated with, or predict, effective viral suppression or functional cure of chronic infection under certain antiviral
treatments. The composition of the low-density PreC/eAg proteins will be explored by analyzing their association
with one or more extracellular vesicles or with lipoproteins. Successful completion of the proposed research will
have a significant impact on identifying new viral and host factors involved in HBV persistence and may establish
the low-density PreC/eAg population as a potential biomarker for predicting progression to chronic HBV infection
and/or outcome of antiviral treatment.

Public health relevance
Project Narrative Chronic infection with hepatitis B virus (HBV) presents a global public health burden affecting 296 million individuals worldwide, who are at high risk of developing severe liver diseases, including cirrhosis and hepatocellular carcinoma. Our proposed research seeks to explore the distinct functions of the HBV PreCore- derived proteins in modulating the outcome of HBV infection, as well as to identify their associated host factors and dynamic changes related to infection outcome and antiviral treatment. Our project will characterize new virus-host interactions linked to viral persistence and their use as a potential biomarker predicting HBV infection and treatment outcomes.